On differentiating selective and neutral evolutionary processes

Jensen, Abstract
At the founding of population genetics in the early 20th century, S. Wright and R.A. Fisher
developed much of the mathematical framework underlying the study of population-level
processes dictating variation observed within- and between-species. However, as evidenced by
decades of published interactions, they held strongly differing views regarding the relative
importance of adaptive vs. non-adaptive processes in driving evolution. As pointed out by J.
Crow (2008), these issues were not really resolved, but "rather they were abandoned in favor of
more tractable studies." With the proposal of the Neutral Theory by M. Kimura and T. Ohta, the
relative contribution of stochastic effects, as earlier advocated by S. Wright, received renewed
attention. In the following decades, further theoretical development as well as the availability of
large-scale sequencing data have indeed overwhelmingly justified the important role of genetic
drift. However, subsequent research related to linked, rather than direct, selection effects have
re-ignited previous debates. The primary difficulty in addressing this question has historically
stemmed from our lack of an appropriate evolutionary baseline model - that is, a model jointly
incorporating constantly and commonly acting evolutionary processes. This would necessarily
include genetic drift as modulated by a realistic demographic history, as well as a realistic
distribution of fitness effects summarizing the pervasive effects of both direct and linked
purifying selection. Without this baseline model incorporating these evolutionary processes that
are certain to be occurring, it is simply not feasible to accurately quantify the episodic frequency
with which rarer processes (e.g., positive and balancing selection) may be further acting to
shape patterns of polymorphism and divergence. During our current funding period, we have
addressed this decades old limitation by developing population genetic theory and methodology
to jointly estimate the parameters underlying such a baseline model, and we have applied these
developments to a number of critical species (including humans, genetic model systems such
as Drosophila melanogaster, and critical pathogens including influenza A virus and SARS-CoV-
2). These developments have been made in parallel for organisms well fit by Kingman
coalescent assumptions (e.g., mammals) as well as those with highly skewed progeny
distributions which necessitate a more generalized multiple-merger coalescent framework (e.g.,
viruses). In this renewal, I propose to build upon this baseline modeling to additionally infer,
identify, and estimate the genomic contributions of the episodic processes of positive and
balancing selection, and to extend our evolutionary baseline inference across the primate clade.

Public health relevance
Jensen, Narra*ve One of the greatest challenges facing the biological, medical, and statistical sciences today is the extraction of useful and accurate information from the vast amounts of existing and newly emerging genomic data. While great advances have been made, a major limiting factor has long been the inability to jointly estimate an appropriate 'evolutionary baseline model' consisting of the suite of certain and constantly-operating evolutionary processes known to be fundamentally shaping genomic variation; however, we have provided an important solution to this constraint during the current funding period as described herein. In this renewal application, I propose additional methodological developments to build upon this baseline modeling to identify and characterize the contributions of rarer evolutionary processes (e.g., positive and balancing selection), and to apply this approach to biomedically-relevant primates as well as across RNA and DNA viruses of critical public health concern.